Reproducibility statistics and machine learning methods for systematic phenotyping and model integration across animals, organs, and technologies

Project Summary/Abstract
Modern high throughput biomedical research is collecting an ever-increasing number of variables spanning different
physical scales, systems, and species. In this era of “multi-omics”, multiple data sets are often collected on the same
animal, spanning modalities that may variously include genomics, transcriptomics, proteomics, epigenomics,
metabolomics, connectomics, and other “omics” domains, with each individual omics data set consisting of hundreds up
to hundreds of thousands of variables. These exciting developments in data acquisition have led animal model researchers
into a new data paradigm, with many labs now relying on machine learning methods for dimensionality reduction,
clustering, phenotyping, data integration, and similar techniques assembled into pipelines as part of standard practice.
Frequently in this scenario, the number of variables collected p (e.g., metabolites) becomes as large as (or larger than) the
number of observations n (e.g., mice). In statistics, this is referred to the Large Dimensional Limit (LDL) regime2.
This dramatic increase in the number of variables relative to observations changes the statistical behavior of the
data, leading to significant problems with machine learning model fitting behavior that are not widely appreciated outside
certain domains of mathematical statistics and physics. Estimates that should fundamentally describe the structure of data,
such as the principal components, no longer converge to their true underlying values (as they do in the classical “small
data” case when p is much smaller than n). Further, similar failures extend far beyond principal components impacting
many other widely used machine learning approaches, and multi-stage analysis pipelines and complex animal data
distributions further compound these problems, collectively resulting in a modern reproducibility crisis in animal research.
Here we show that these issues also broadly impact the test-retest reproducibility of machine learning methods on
held out data, with reproducibility on new data following a “universal reproducibility curve” in which performance
changes rapidly from non-reproducible to reproducible as a function of sample size and number of variables. A direct
consequence of this phase transition is that modern animal model research studies are subject to a reproducibility
transition such that below a certain value p/n machine learning algorithms fail to yield reproducible results. Furthermore,
for ratios of p/n above this value, collecting additional data will yield rapidly diminishing marginal returns in
reproducibility that may not be justified by data acquisition costs or trade-offs. Together these phenomena define what we
call “universal reproducibility curves” that depends on the “aspect ratio” p/n of the data (as well as the strength of the
multivariate biological signal that the data contain). Gaining a mechanistic understanding of such curves will allow us to
systematically solve important open problems in machine learning such as how to measure reproducibility across machine
learning methods and pipelines, how many data samples to collect and how many variables to measure to ensure
reproducibility, when to stop collecting data, and how to design better embedding algorithms for data integration and
systematic phenotyping in real-world animal research models.

Public health relevance
Project Narrative Successful translational research requires that studies in animal models be rigorous and reproducible. We introduce and propose studying what we call “universal reproducibility curves”: theoretically grounded yet concretely computable statistics for model reproducibility designed to be appropriate for preclinical research data. Gaining an understanding of such curves and related statistics would allow us to systematically solve important open problems such as how to measure reproducibility, how many data samples to collect, and how many variables to measure to ensure reproducibility when applying complex machine learning pipelines, integrating data, estimating phenotypes, and translating across species.